Biological Data Acquisition and Analysis Core

The objectives of the Biological Data Acquisition and Analysis Core are the following: 1) to enhance the
biological resources of existing Center studies and pilot studies; 2) to maximize their productivity with existing
biological resources; 3) to inform, educate and train Center investigators, affiliates, postdoctoral fellows, and
students on novel and innovative biological methods; and 4) to promote collaborative science across Center
projects. The core staff will provide individualized consultation with Center projects to evaluate resources and
opportunities, develop a plan to enhance resources and initiate collaboration, provide project management
support to ensure smooth coordination with facilities and timely completion, supplement project resources to
assist with data analysis and writing, and provide access to training/educative opportunities to investigators
and staff. The team will be co-led by Dr. Timothy Strauman, who has expertise in the use of brain imaging
techniques to study mechanisms relevant for self-regulation, and Dr. Cynthia Kuhn, a pharmacologist, whose
laboratory will provide a core facility for studies looking to assay stress and immune-related biomarkers. Their
team will be joined by a set of partner facilities/resources in genomics/epigenetics, neuroimaging, biomarker
assessment, electronic health records, bioinformatics and biobanking. Matching these resources with Center
projects will stimulate novel insights into the interplay between early experiences, regulatory processes,
underlying biological systems, and behavioral outcomes.